Promoting Physical Activity to Improve Cognitive Function in Older Adults Undergoing Hematopoietic Cell Transplantation (HCT)

PROJECT SUMMARY
Cancer and treatment-related cognitive changes cause distress, hinder resumption of normal routine and roles,
and worsen quality of life. Hematopoietic cell transplantation (HCT) is a potentially life-prolonging treatment for
patients with hematological malignancies. HCT differs from the delivery of chemotherapy in other cancer settings
due to the intensity of chemotherapy and severity of toxicity. Previously reserved for younger patients, in the past
decade a growing number of adults 60 years of age and older have received this intense treatment. Our
preliminary data shows that post-HCT, 35% of older patients experience significant cognitive impairment
compared to 19% pre-HCT. Physical activity improves cognitive function in older adults and survivors of other
cancers. While untested in older adults undergoing HCT, we hypothesize that increasing physical activity can
also improve cognitive function in this vulnerable population. The objective of this proposal is to adapt and test
an evidence-based physical activity intervention, The Community Health Activities Model Program for Seniors II
(CHAMPS II), in the HCT setting to improve cognitive function for adults 60 years and older. This program is
effective in increasing physical activity for sedentary community-dwelling older adults with multiple chronic health
conditions. We will iteratively adapt and implement CHAMPS-II in three waves. During each wave, 2-4
patient/care-partner dyads will participate in a multi-phase, light- to moderate-intensity physical activity program.
We will use a Type 1 hybrid effectiveness-implementation design to determine the preliminary effectiveness of
the adapted intervention to improve cognitive function compared to an active control condition (N = 34 per group).
This novel trial design spans the effectiveness and implementation research to accelerate the translation of
physical activity interventions into practice for older adults with cancer. The translation of physical activity
interventions into clinical practice remains challenging within cancer survivorship, despite promising evidence of
efficacy in improving functional outcomes and quality of life. To become an independent researcher who
develops, implements, and disseminates interventions that prevent cognitive decline and improve functional
outcomes for older patients with cancer, Dr. Koll requires additional training and experience in: 1) physical activity
promotion and principles of exercise training; 2) design and conduct of hybrid effectiveness-implementation
clinical trials; and 3) leadership and project management skills needed to execute translational studies requiring
collaboration between researchers and clinicians. An outstanding team of mentors and advisors support this
proposal with expertise in geriatrics (Fisher), behavioral and implementation science (Estabrooks), clinical
exercise trials in older adult and cancer populations (Ehlers), geriatric oncology (Wildes), cognitive disorders and
cognitive aging (Murman), and mixed methods (Jones). The training and research plan will position Dr. Koll to
become one of the few geriatricians with expertise in cognition and cognition-enhancing interventions in older
adults with cancer.

Public health relevance
PROJECT NARRATIVE The number of older adults who are 60 years and older undergoing hematopoietic cell transplantation as part of cancer treatment has more than doubled in the past decade. Older adults undergoing these transplants are at high risk of experiencing a decline in cognitive function afterwards that can affect day-to-day function and quality of life. Our project seeks to develop and test an exercise-based intervention to preserve cognitive function and improve quality of life among transplant recipients.